Long noncoding RNA expressing genomic elements that control antibody diversification and chromosomal integrity in B cells

PROJECT SUMMARY
Background. It is now evident that the majority of the mammalian genome has the potential to express non-
coding RNAs (ncRNAs). However, the functionality and mechanism(s) of regulation of these ncRNAs are just
beginning to be explored. One challenge that biologists encounter is the detection of these ncRNAs, which
often tend to be transcriptionally tightly controlled and rapidly degraded. Using mouse models that allow easy
detection of lncRNA, we have recently identified a set of long noncoding RNAs (lncRNA) that are expressed
surrounding the immunoglobulin loci genes. These lncRNAs are placed inside topologically associating
domains (TADs) that are formed during B cell development. Experiments using mouse models that lack these
lncRNAs (published and preliminary data) demonstrate roles in class switch recombination and somatic
hypermutation mechanisms.
Objectives/Hypothesis. Here we investigate the direct role of lncRNAs in regulating genome local
architecture and DNA topology via cis and trans mechanisms. In aim 1: we evaluate the physiological role of
lncRNA-expressing loci in regulating IgH recombination via organizing TADIgH; in aim 2, we understand the
molecular mechanisms through which lncRNAs are used to control genome architecture; and in aim 3, we
focus on understanding the function of lncRNA SµGLT in control of CSR.
Study Design: Using mouse models and cell lines that are deficient in specific lncRNAs we aim to investigate
their immunologically relevant functions. For evaluating the molecular mechanism of action of the lncRNAs we
use biochemical assays to purify lncRNA interacting proteins and perform chromosomal architecture assays
such as HiC and 4C-seq. Finally, we perform high-throughput sequencing experiments to evaluate the
lncRNA's effect(s) on SHM in the Ig loci genes and elsewhere.
Disease Relevance: The proposed studies will lead to a better understanding of the mechanisms in B cell
development and function. The lncRNAs being investigated in this application carry polymorphisms in patients
with IgA deficiency syndrome and thus our study is relevant for human physiology. Finally, antibody
diversification mechanisms are essential for immune system homeostasis but when these mechanisms fail
there are increased genomic alterations that are associated with lymphomas. Thus, this study is related with
both immunity and lymphomagenesis.

Public health relevance
PROJECT NARRATIVE The correct topological organization of the B-lymphocyte genome during development and antibody gene diversification events prevents aberrant chromosomal translocations and promote antibody diversification mechanisms. Recent advances in transcriptomics and genomics have identified the role of long noncoding RNA expressing enhancer sequences in the organization of B cell genomes. In this application, we evaluate the role of three long noncoding RNA expressing loci in maintaining the correct architecture and local topology of B cell genomes and for promoting antibody diversification.